Herpesvirus gene expression in transformed cells

[unreadable] DESCRIPTION (provided by applicant): Certain cancers occur as a consequence of infections with particular herpesviruses. In addition, most people become infected with one or more herpesviruses, which can persist indefinitely in quiescent state but then reactivate in immunosuppressed individuals, including cancer patients, to cause significant disease. The studies described here are directed toward understanding basic mechanisms that are central to herpesvirus infection of cells and spread from cell-to-cell, namely the mechanisms of herpesvirus-induced membrane fusion. Herpesvirus entry into cells requires fusion of the outer envelope of the virus with a cell membrane. Spread of infection can occur via infectious virus or virus-induced cell fusion. The ultimate objective of studies described here is to understand how herpesviruses, specifically herpes simplex viruses (HSV), induce membrane fusion, the process required for viral entry and cell fusion. Requirements for HSV-induced membrane fusion include the coordinated activities of four HSV glycoproteins (gB, gD, gH and gL) and interaction of gD with a cell surface receptor such as nectin-1. Our hypothesis is that binding of gD, present in the viral envelope or an infected cell surface, to a gD receptor on an uninfected cell somehow activates the fusogenic activity of gB and/or gH-gL (a heterodimeric complex). This activation could result from the physical interaction of gD (altered by its binding to receptor) with gB or gH-gL or both. Alternatively, the gD- receptor interaction could activate gB or gH-gL by some indirect transmission of a signal. The specific aims are (1) to define the sequence requirements for a region of gD that is required for cell fusion, but not for receptor binding; (2) to identify regions of gB and gH that are essential for membrane fusion, through random mutagenesis and cell fusion assays; (3) to define conditions or mutations in gB that permit cell fusion to be induced by gB in the absence of gD and/or gH-gL; (4) to identify protein complexes that contain gD plus one or more of the other viral glycoproteins, that are induced in response to gD-receptor interaction and that fail to form when either gD or one of the other glycoproteins is non-functional for membrane fusion. The results of these studies, combined with structural studies in progress in other laboratories, will lead to an understanding of the mechanism(s) of herpesvirus-induced membrane fusion and to new approaches for the prevention and treatment of herpesvirus infections and disease. [unreadable] [unreadable]